Improving bacterial cancer therapeutics

PROJECT SUMMARY (ABSTRACT)
Bacterial cancer therapy has existed since Dr. William Coley employed deliberate
bacterial infection of tumors over a century ago in the first known example of cancer
immunotherapy. Bacteria are genetically tractable self-replicating therapeutics which can be
tuned to deliver various payloads, modify specificity, and decrease side effects. Additionally,
intravenously administered bacteria (particularly Escherichia and Salmonella) are intrinsically
capable of selectively colonizing tumor tissue in mouse models, showing reduced colonization
with rapid clearance from other organs. These properties make bacteria attractive potential
vehicles for delivering cancer therapy. However, early clinical trials have been stymied by low
colonization rates in human patients. Though much work has been done to develop therapeutic
payloads for bacterial delivery, comparatively little is known about the mechanisms by which
bacteria colonize tumors and thereby deliver these payloads. At present, there is little pre-
existing literature using comprehensive and unbiased screens to identify pathways for tumor-
specific bacteria colonization. These screens are urgently needed to not only identify essential
pathways for tumor colonization by bacteria, but also to identify pathways which may be
manipulated to increase tumor-specific colonization by bacteria. This information can be
leveraged both to identify pathways essential for tumor colonization and to develop strains with
increased tumor specificity. By identifying these genes, this project aims to understand the
mechanisms by which E. coli specifically migrate to and grow within tumors and identify targets
which can be manipulated to tune colonization efficiency and specificity. Ultimately, this work
will advance the production of living medicines as cancer therapy. The strong community of
immunologists, synthetic biologists, and bioinformaticians supervising the trainee's work will
support this fellowship. Throughout the award, the trainee will benefit from the outstanding
training environment at Columbia in both research and clinical components, as well as the
integration of the two distinct disciplines in training physician scientists, to develop fundamental
skills for becoming an independent physician investigator.

Public health relevance
PROJECT NARRATIVE Bacteria programmed to make anti-cancer drugs will grow inside tumors but not normal organs, which means they can be used to specifically deliver drugs to tumors and metastases and reduce side effects. However, bacteria don’t colonize human tumors very well, and we don’t really understand why. We will use many strains of bacteria with mutations in different genes to see which genes affect colonization of tumors, which will let us make anti-cancer bacteria that are even more specific to tumors.